Approach Bias Retraining for Nicotine Addiction among Dual Combustible and Electronic Cigarette Users

PROJECT SUMMARY
Electronic cigarette (ECIG) use has become a popular method for nicotine delivery. Combustible cigarette (CC)
cessation or reduction are the primary reasons for ECIG uptake among adults.1-3 Yet, most CC smokers who initiate
ECIG use do not fully transition from CC to ECIG, despite intending to quit CC completely.4-9 Longitudinal work has
found that 89% of dual users—users of ECIG and CC concurrently--remain dual users a year after initial
assessment.10 Theory and empirical findings suggest that targeting automated, impulsive, implicit processes may
hold promise for substance use reduction and cessation.11-16 Specifically, retraining approach bias, or the approach
action tendency toward stimuli related to the substance of interest, has been effective in alcohol use disorders (i.e.,
reduction in relapse rates by 10%-13%).16-18 When applied to CC-related stimuli, approach bias retraining has been
found to reduce approach bias, which is subsequently related to greater number of days abstinent from CC
following a self-guided quit attempt.19
The parent grant will evaluate the initial efficacy of approach bias retraining among dual CC/ECIG users as well
as putative mechanisms of treatment effects. In addition, the current supplement research project proposes to test
clinically-relevant sociodemographic moderators (i.e., sex, race, and nicotine dependence [CC dependence and
ECIG dependence separately]) of treatment effects and mechanisms. We will randomly assign 90 dual CC/ECIG
using adults to one of three conditions: (1) CC+ECIG retraining; (2) CC only retraining; and (3) sham training
(control). Participants will complete 4 sessions of approach bias retraining using the respective stimuli and then
engage in a self-guided quit attempt to abstain from all nicotine products. Each session will consist of 15 minutes of
computerized approach bias retraining and a brief assessment. Participants will provide baseline data, ecological
momentary assessment (EMA) data during the first two weeks post-intervention, and complete follow-ups at 4- and
6-weeks post-intervention. Abstinence will be assessed during the intervention (weeks 0-4), during the EMA period,
and at both follow-ups. Upon completion of data collection, we will run tests of moderation exploring sex, race, and
nicotine dependence (CC and ECIG dependence separately) as independent moderators of treatment effects for
point-prevalence abstinence, prolonged abstinence, and putative mediational pathways. This work is key to identify
individual differences that may affect the efficacy of the intervention and its mediational pathways.
The proposed supplement represents a crucial and important ‘next step’ in translating basic research strategies
for treating nicotine dependence among dual CC/ECIG users. It will yield important findings to help us evaluate
whether approach bias retraining interventions administered to dual users have a differential impact by sex, race,
and perhaps nicotine dependence. This knowledge is critical to understand if the intervention needs to be adapted
for specific subgroups. This supplement will enhance our ability to examine the efficacy of the intervention across
subgroup populations and inform ‘next steps’ in adapting approach bias retraining for dual users.

Public health relevance
PROJECT NARRATIVE Nearly half (40.8%) of electronic cigarette (ECIG) using adults report dual ECIG and combustible cigarette (CC) use, which is concerning from a public health perspective given (1) dual CC/ECIG users are apt to experience cancer and tobacco-related health risks at rates comparable to exclusive CC users and (2) dual CC/ECIG use may prolong and sustain nicotine addiction, and consequently, inhibit CC cessation among those who might otherwise quit; yet, little is understood about clinical pathways to support CC and ECIG cessation among dual users. As such, the parent study will evaluate CC and ECIG quit patterns following a theoretically and empirically supported brief computerized intervention that targets approach bias toward drug-related stimuli (i.e., CC and ECIG stimuli) among dual users and examine putative mediators of treatment efficacy. In extension of this clinically-relevant and highly impactful work, the present supplement will explore potential sociodemographic moderators (i.e., sex, race and nicotine dependence [CC and ECIG dependence separately]) of treatment effects on cessation outcomes and mediational pathways to account for individual differences that may affect the efficacy of the administered approach bias retraining intervention; this work has the potential to inform a precision-science approach to personalized, tailored treatment development for dual CC/ECIG users (an underserved and understudied emerging health disparities group).